Macromolecular Structure and Mechanism

Project Summary
This Training Program provides graduate students with advanced education in the principles
and practice of macromolecular chemistry, mechanism, and structure. All aspects of the
program - formal course curriculum, laboratory rotations, informal specialized area-interest
seminars, and intensive research in laboratories operating on the edge of discovery - are aimed
at the question: how do biological macromolecules work? How do proteins, membranes,
nucleic acids, and high-order complexes of these huge molecules use physical-chemical and
structural principles to act in the enormous variety of contexts that underlie biological function?
The Training Program provides support for selected students in the Graduate Program in
Biochemistry and Biophysics at Brandeis University. This is a flexible PhD program designed for
two broad types of students: those with strong quantitative backgrounds but who may have
weaker prior training experience in biological chemistry, and those with more traditional training
in biochemistry and cell biology. Our intention is to bring these two groups of students to the
same end-point and to prepare them for careers in basic research. Currently, 34 students are
enrolled in this Ph.D. program; the Training Program includes 25 participating faculty, from four
departments, working in the following areas: macromolecular structure determination by x-ray
crystallography and NMR, mechanistic enzymology, bioinorganic chemistry emphasizing epr
and Mössbauer spectroscopy, membrane transport and ion channel mechanisms, single-
molecule analysis, virology, chemical biology, computational biophysics, and protein evolution.

Public health relevance
Project Narrative: A general rationale for the value of this program is the conviction that human disease must ultimately be understood in terms of the chemistry and physics of biological macromolecules.